Biomechanical Basis of Sex Differences in Concussion and Subconcussion

PROJECT SUMMARY
Sex is an important risk factor to consider in concussion but has been historically under-studied. Computational
models of the human head transform external head impacts into regional brain strains that are well believed to
be the primary cause for injury. They are thought to offer more effective biomechanical mechanism underpinning
concussion. However, current brain injury models do not consider sex differences in morphology, either at the
organ level or at the microscale, axon level. Therefore, current brain injury models are not feasible to study the
biomechanical basis of sex differences in concussion. This proposal has two specific aims. First, we will develop
subject-specific brain injury models of the whole brain and axons. Next, we will use subject-specific head impacts
from male and female ice-hockey players to characterize sex differences in brain strain and extent of axonal
damage, and then correlate them with a range of biomarkers. Sex differences in both concussion and
subconsussion will be studied. The proposed research will provide an initial understanding of the sex-related
differences in strains sustained in male and female brains and the extent of axonal structural damages. Ultimately,
these efforts will contribute to refined health policymaking and sex-specific concussion mitigation strategies to
reduce the growing health-care burden.

Public health relevance
PROJECT NARRATIVE Sex differences in concussion is important but little studied. We propose to develop subject-specific multiscale computational models to study the biomechanical basis of sex differences in concussion and subconcussion. We will characterize sex differences and validate the approach with a range of biomarkers using data from male and female athletes participating in contact sports and noncontact controls.